An Open-access 700 MHz NMR Spectrometer for Central New England

Support for the acquisition of a state-of-the-art open-access 700 MHz NMR spectrometer for
researchers in central New England is requested. The instrument will be located at UConn
Health in Farmington, CT, in the Gregory P. Mullen NMR Structural Biology Facility, which
currently houses spectrometers operating at 400, 500, 600, and 800 MHz. The Facility is
operated by a full-time manager supported by the University of Connecticut and additional
part-time staff. In addition to providing robust HVAC, power, and network infrastructure, the
facility operates a helium-recovery system for sustainable operation. The 700 will be utilized by
a core group of experienced investigators from the UConn Storrs and Farmington UConn
campuses, the University of Massachusetts (Amherst), Brown and Wesleyan Universities, and
Worcester Polytechnic Institution, and will be available to others. Participating investigators will
obtain access on a priority basis, determined by a multi-institution scheduling committee. The
group of participating investigators comprises 18 laboratories, 11 of which use NMR as a
primary research tool, and has demonstrated outstanding NMR-based research into protein
structure, function, and dynamics, and on small biomolecules, through a record of publication
and external funding. The 700 will complement the existing resources available to these
researchers, will provide a unique field strength for field-dependent investigations of protein
dynamics, and will enable the investigation of larger, more complex systems through its
improved resolution and sensitivity compared to the obsolete, unsustainable 500 MHz
instrument that it will replace. Gains in resolution will result from increased dispersion of
nuclear resonances, simplified coupling patterns for small biomolecules, and larger TROSY
effects for macromolecules. Studies to be supported by the 700 include transiently populated
protein states involved in molecular recognition proteins, proteins that participate in repair and
replication at sites of DNA damage, proteins that protect from DNA damage, molecular
chaperones, proteins that function as tumor suppressors and their mutants, dynein molecular
motor proteins, proteins that function in cell division, cell signaling proteins, enzymes involved
in antibiotic resistance, hemopoeitic cytokines and their receptors, viral (including SARS-CoV-2)
proteins, metabolomics, and plant natural products. The shared instrument will be supported
by the Network for Advanced NMR, ensuring easy access, efficient use, and comprehensive
data stewardship.

Public health relevance
PROJECT NARRATIVE Investigators from 6 institutions in Central New England seek to acquire a state-of-the-art 700 MHz NMR spectrometer to serve as a regional resource in support of studies on biomacromolecular structure, dynamics and interactions, and the analysis of mixtures of small biological molecules. The supported studies have relevance to cell signaling, cancer, infectious disease, metabolic disease and biomarker discovery.